A multi-function earplug that measures in-ear noise, standard noise dosimetry and hearing function

PROJECT SUMMARY/ABSTRACT
22 million U.S. workers are exposed to hazardous noise levels each year and approximately 16% of disabling
hearing loss worldwide is work-related. In the US, despite significant regulations and the implementation of
hearing conservation programs for decades, 25% of workers associate their hearing difficulties with workplace
exposures. Typically, individual hearing monitoring is conducted yearly which can only provide a record of the
progression of irreversible hearing loss with limited options for intervention and mitigation. Furthermore, there is
limited data that links actual, real-world noise exposure to noise induced hearing loss (NIHL) making it very
difficult to develop evidence-based damage risk criteria. Creare proposes to design, build, and test a
multi-function earplug that will (1) provide hearing protection during activities in noisy environments; (2) record
personal noise dose; and (3) monitor hearing function over time. Our integrated in-ear hearing monitoring and
protection system will allow users to monitor the potential impact of hazardous noise as close to the exposure
as is possible, and eventually enable real-time intervention such as better engineering controls, changes in work
schedules, better personal protection or even pharmaceuticals to mitigate pre-clinical hearing damage and
prevent NIHL. We have assembled an expert team that is uniquely positioned to develop this technology thanks
to its active involvement in the development of innovative technologies for hearing assessment, hearing
protection, and dosimetry for individuals working in noisy settings.

Public health relevance
PROJECT NARRATIVE People who work in noisy environments such as construction, mining, forging, and many other occupations are much more likely to develop hearing loss as compared to workers in other industries, even when they wear hearing protection. In this project, we will work to develop a new earplug that will allow workers to measure the noise coming to their ears throughout the day and to measure possible changes to their hearing at the end of a shift. Researchers who use the device in their studies will also be able to better understand how different types of noise, and how combinations of noise and chemicals, affect workers’ hearing; ultimately, this will help Health and Safety professionals to improve hearing loss prevention in the workplace.